Radiomic spatial maps for identifying viable tumor extent on multi-parametric MRI for Glioblastoma

ABSTRACT: Glioblastoma (GBM) has a complex infiltrating tumor microenvironment which extends well beyond
the visible enhancing tumor margins and plays a substantial role in GBM recurrence and poor outcomes.
Unfortunately, in the absence of a precise spatial map of tumor extent, it is often difficult to differentiate infiltrating
tumor from vasogenic edema on clinical MRI during radiation/surgical planning. The untreated infiltrating tumor
ultimately contributes to over 90% of GBM recurrences. An equally pressing challenge is the difficulty in
distinguishing recurrent tumor from treatment-effects following chemoradiation. Due to the histologically diverse
landscape of post-treated lesions, treatment-effects often co-exist with tumor recurrence, and mimic appearance
on imaging. In the absence of reliable tools, 15-20% of patients with GBM recurrence are incorrectly diagnosed
due to sampling error associated with intracranial biopsy. Thus, developing a non-invasive spatial map of
GBM tumor extent that can reliably identify infiltrating/recurrent tumor from confounding pathologies (treatment-
effects/edema), will have significant implications in radiation/surgical-planning and post-treatment management.
Recently, we developed a Radiomic-Image (Rad-I) map of tumor extent that uses computational features
corresponding to the micro-architectural image measurements of disorder in the local intensity gradients (i.e.,
gradient entropy). The initial version of the Rad-I map has been evaluated to distinguish recurrent tumors versus
treatment-effects on post-treatment Gd-T1w MRI with an 85% accuracy on n=75 studies, and to distinguish
infiltrating tumor versus vasogenic edema on pre-treatment MRI scans with a 94% accuracy on n=42 studies.
In this R01 project, we propose to improve on our initial version of Rad-I map by incorporating (1) additional
anatomical (T2w, FLAIR) and functional MR sequences (perfusion) and (2) a novel “lesion complexity” feature,
which captures organizational changes in the tissue composition via graph-theoretic approaches on MRI scans.
Overcoming limitations pertaining to small cohorts and lack of spatially mapped ex-vivo histology for validation,
Rad-I maps will be extensively validated on (1) a large multi-institutional MRI cohort with co-localized
histopathology and (2) the PRESERVE clinical trial designed to capture GBM heterogeneity via multiple co-
localized tissue samples/lesion. These cohorts will also allow for establishing associations of our new radiomic
features with underlying histological/molecular tumor characteristics- a prerequisite for clinical adoption. Lastly,
Rad-I maps will be evaluated within a tumor board survey to address the clinically challenging problem of
distinguishing recurrent tumors versus treatment effects. Criteria for success for Rad-I maps are that they are
at least non-inferior to the accuracy of stereotactic biopsies (85-90%) in identifying tumor niches corresponding
to (a) viable/infiltrating tumor vs. edema and (b) recurrent tumor vs. treatment effects. Multi-institutional validation
and end-user (tumor board) feedback will further confirm the utility of Rad-I maps as a noninvasive alternative to
surgical biopsies; thereby paving the way for radiation/surgical and post-treatment management in GBM tumors.

Public health relevance
Relevance: The goal of this project is to develop radiomic-image (Rad-I) maps of spatial tumor extent on clinical MRI scans and histopathologically validate their efficacy in non-invasively distinguishing (a) viable/infiltrative tumor from vasogenic edema and (b) tumor recurrence from treatment-related effects, in glioblastoma tumors. Our proposed multi-institutional validation will demonstrate the clinical utility of Rad-I maps as a noninvasive alternative to stereotactic biopsies in identifying the tumor extent, ultimately paving the way for tailored surgical and post-treatment response management, thereby improving long-term outcomes in patients with glioblastoma.